Dissemination Core

Core 4 Project Summary
In the next project period, the Dissemination Core will leverage strengths, resources, and existing programs
within our Atlanta-based institutions and supplement them with valuable, tailored programs designed to achieve
our collective ACME POCT goals. Personnel from the Dissemination Core will interface with ACME POCT core
leaders and personnel, project inventors, and other stakeholders towards driving several important ACME POCT
functions. At the Center level, Core 4 will be responsible for assessing needs and developing cross-disciplinary
training activities for all stakeholders involved (clinicians, microsystems engineers, POC diagnostic developers,
patients, policy makers, investors, public) and will ensure information dissemination is effective. Core 4 will also
take the lead and seek inputs from all stakeholders to define the clinical needs and will continuously canvas our
development ecosystem to collect data related to lessons learned and best practices. At the program/project
level, our Core experts will conduct an initial Clinical Needs Assessment to drive subproject solicitation, initial
evaluation, selection, and “intake” of microsystem-based POC technologies into the ACME POCT.